MISOPROSTOL ON ADVERSE RENAL EFFECTS AND IBUPROFEN IN RENAL INSUFFICIENCY

Asses the influence Misoprostol has on the renal protective role in patients with chronic renal insufficiency. Analyze the influence of misoprostol has on the pharmacokinetics of ibuprofen.